Project 1

U54 Research Project 1: Disparities in environmental exposures and health impacts
Abstract
The main premise of the proposed research is that health disparities in the eastern
Coachella Valley (ECV), especially with regard to asthma and cardiopulmonary disease within
the Latino community, are significantly affected by differential chronic environmental exposures
to aerosols including biological materials (e.g., allergens and microbial components). To focus
on the specific question of environmental exposures and health, we aim to develop a monitoring
protocol and database that would allow us to assess correlates between aerosolized particulate
components, effects on pulmonary inflammatory responses, and the epidemiology of asthma
and other cardiopulmonary diseases in the Coachella Valley. We aim to accomplish this in
conjunction with a community advisory board to enable continuous community engagement.
The research program will include transport studies to identify patterns of particle/pollutant
transport in the Coachella Valley, collection of particulate, soil and water samples in and near
the Salton Sea to track the origins and movement of biological components in aerosols, and
exposure of the collected material in mouse models to identify materials that may contribute to
lung inflammation and asthma in the community.